STRUCTURAL ANALYLSIS OF O-LINKED OLIGOSACCHARIDES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Methods: Release of N-linked glycans The sample was dissolved with 0.1 M Tris-HCl buffer (pH ~8.0) and heated at 100[unreadable]C for 5 min to denature the protein. After cooling to room temperature, the sample was treated with trypsin and chymotypsin and incubated at 37oC overnight. The tryptic-chymotryptic digest was passed through a C18 sep pak cartridge, cleaned with 5% acetic acid, and the glycopeptides/peptides were eluted subsequently in series with 20% isopropanol in 5% acetic acid, 40% isopropanol in 5% acetic acid and 100% isopropanol. The eluate was dried initially under a stream of nitrogen gas and eventually lyophilized. The dried eluate was dissolved with sodium phosphate buffer, treated with PNGase F and incubated at 37oC for 18 hours to release N-linked glycans from the polypeptide chains. After incubation, the enzyme (PNGase F) digest was passed through a C18 sep pak cartridge and the N-linked glycans fraction was eluted first into a tube with 5% acetic acid followed by the elution of O-linked glycopeptides/peptides into another tube with 20% isopropanol in 5% acetic acid, 40% isopropanol in 5% acetic acid and 100% isopropanol. The O-linked glycopeptides/peptides fraction was dried under a stream of N2 gas. Release of O-linked glycans by [unreadable]-elimination O-linked carbohydrates were cleaved from the glycopeptides by [unreadable]-elimination procedure. Briefly, 250 [unreadable]L of 50 mM NaOH were added to each of the samples and then checked for pH. Upon determination that the pH was basic, another 250 [unreadable]L of 50 mM NaOH containing 19 mg of sodium borohydride was added to the sample, vortexed, and incubated overnight at 450C. The incubated sample then was neutralized with 10% acetic acid and desalted by passing through a packed column of Dowex resins and then lyophilized. The dried sample was cleaned of borate with methanol:acetic acid (9:1) under a stream of nitrogen gas before permethylation. Per-O-methylation of carbohydrates The O-linked glycans were permethylated for structural characterization by mass spectrometry (Anumula and Taylor, 1992). The dried eluate was dissolved with dimethylsulfoxide and methylated with NaOH and methyl iodide. The reaction was quenched with water and per-O-methylated carbohydrates were extracted with methylene chloride and dried under N2. Profiling by Matrix-Assisted Laser-Desorption Time-of-Flight Mass Spectrometry (MALDI-TOF MS) The permethylated glycans were dissolved with methanol and crystallized with [unreadable]-dihyroxybenzoic acid (DHBA, 20 mg/mL in 50% methanol:water) matrix. Analysis of glycans present in the samples was performed in the positive ion mode by MALDI-TOF-MS using Bruker microflex .